Sorting and characterization of cancer cells based on metabolic phenotype

PROJECT SUMMARY/ABSTRACT
Altered metabolism is a hallmark of cancer, and therapeutic intervention of this altered feature is emerging and
holds significant potential. Recent work has found that breast cancer cells exhibit dramatic differences in their
glycolysis versus oxidative phosphorylation (OXPHOS) metabolic phenotype within the primary tumor and
metastases, and between metastases at different organs. This heterogeneity in metabolic phenotype may be a
result of genetic heterogeneity or cellular plasticity and metabolic adaptation to the local microenvironment.
Metabolic heterogeneity and plasticity may contribute to therapeutic resistance to treatments that target a specific
metabolic pathway. The field generally believes that cellular metabolic adaptation and plasticity facilitate their
survival and colonization during metastasis. However, it not clear whether a change in metabolic phenotype in
the primary tumor can predict metastatic outcome. In this project, we propose to phenotypically sort breast cancer
cells into subpopulations with distinct glycolysis or OXPHOS phenotypes, and use these sorted subpopulations
to test the hypothesis that the initial metabolic phenotype and heterogeneity determine the metastatic outcome
against the alternative hypothesis that metabolic adaptation to the local microenvironment and phenotypical
switching contribute to metastatic outcome regardless of the initial metabolic heterogeneity. By expressing a
fluorescent biosensor in the cells for cellular glycolysis versus OXPHOS reliance, we have obtained preliminary
data supporting the feasibility of cell sorting based on this metabolic feature. In Aim 1, we will optimize the
engineering approach for cell sorting based on cellular metabolic phenotype. Fluorescence-activated cell sorting
(FACS) will be coupled with metabolic biosensors, and automated microscopy, photoactivation and fluorescent
labeling of cells for cell separation. In Aim 2, we will use the sorted metabolic subpopulations to test our overall
hypotheses in vitro and in vivo that initial metabolic phenotype predicts metastatic outcome. Engineered systems
mimicking the environmental conditions at the primary and secondary sites, and in circulation will be designed
to characterize cell migration, proliferation, and survival of the subpopulations, as well as their metabolic
adaptation. We will examine the metastatic potential of these subpopulations in a mouse model and determine
their metabolic adaptations at different stages along the metastatic cascade. The innovative aspects of this
proposal are the concept to sort by metabolic phenotype and the goal of uncovering the role of initial metabolic
phenotype in the broader metastatic cascade. This project will use the novel engineered cell sorting approach to
dissect the respective roles of metabolic heterogeneity and adaptability in breast cancer metastasis, thus laying
the foundation for future work to identify the key molecular pathways to precisely target for cancer metabolic
therapy.

Public health relevance
PROJECT NARRATIVE Targeting altered cell metabolism holds great potential for treating cancer because metabolism in cancer cells is dramatically different from that of healthy cells. However, cancer cells exhibit different metabolic phenotypes and they are able to switch between these different phenotypes during metastasis, which allows them to resist and escape therapeutic targeting. This project develops an engineering approach that combines flow cytometry, metabolic biosensor, automated microscopy and photoactivation to isolate and characterize metabolically distinct subgroups of cancer cells, thus providing a versatile tool to understand the effect of distinct metabolic phenotypes on cancer progression.